COVID 19 Supplemental work: HIGH THROUGHPUT BIOMARKER-BASED BIODOSIMETRY

The company is working to develop serology assays for CoV-2 vaccine studies. The project leverages experience in developing and manufacturing high-throughput serology assays, and addresses the need for high quality CoV-2 reagents and tests that can be reproducibly manufactured at large scale. They also propose a study ? in collaboration with Kaiser Permanente - to evaluate measurement of antibodies in saliva to assess immunity to SARS-CoV-2.